ROS Mechanisms in BAV Aortopathy

PROJECT SUMMARY
Ascending aortic aneurysmal disease is a major worldwide health problem. Bicuspid aortic valve (BAV)-
associated aortopathy represents the largest subset of affected patients and this congenital anomaly is present
in 1-2% of the general population. Current aortic diameter-based guidelines for surgical intervention stem from
a non-controlled extrapolation of natural history data that does not reflect patient-specific aortic catastrophe
risk rendering under-treatment in some patients and over-treatment in others. This is largely because there is
an incomplete understanding of what biological and biomechanical features are unique to BAV-associated
aortopathy or other degenerative aneurysms and how these insults potentiate aortic dissection. During the
prior funding period, we uncovered several cellular, tissue architectural, and biomechanical-based features
distinguishing BAV-associated aortopathy from that of degenerative aneurysms. We discovered that elevated
production of superoxide anion by medial smooth muscle cells, increased oxidative stress-induced cellular
damages, and a biomechanical strength profile coupled with an anisotrophic collagen and elastin
microarchitecture uniquely define the tissue microenvironment of the BAV aorta. In the next phase of the
project, we will elucidate how an interplay of mechanical and oxidative stress mediates ECM remodeling,
determine where hypoxia comes into play, and how clinical imaging-derived metrics correspond to cellular and
tissue aberrations in the BAV aorta. In a two-aim approach, we will test the central hypothesis that mechanical
forces- and local hypoxia-induced oxidative stress invokes differential ECM remodeling in BAV and TAV
patients, and these insults can be correlated to patient-specific aortic wall indices that can be imaged, bundled
and used to predict disease progression and/or aortic catastrophe. Aim 1's approach will employ our
established patient-specific 3D culture models to determine how mechanical stretch and low oxygen tension
impact antioxidant response, free radical production, cellular oxidative damages, and influence ECM
production, microarchitecture and degradation in BAV aorta-derived smooth muscle cells. In Aim 2,
quantification of local hypoxic effects, measures of oxidative cellular damages, ECM microarchitecture, and
biochemical ECM composition will be regionally compared and then correlated with patient-specific wall shear
stress measurements from 4D flow MRI, aortic wall morphometrics from dynamic ECG-gated CTA, and
distensibility metrics from echocardiography to develop a workable patient-specific multi-parameter imaging-
based paradigm. Completion of this project phase will generate an aortic bio-map that profiles mechanical and
oxidative stress-mediated ECM remodeling in BAV-associated aortopathy and will identify what in vivo bio-
imaging endpoints correlate with these tissue insults. A perceived deliverable is a set of building blocks for a
workable multi-parameter computational model whose main output will be a patient specific aortic integrity
score that more accurately identifies dissection risk for a given patient. This work will also reveal new
opportunities for the implementation of PET-based probes to non-invasively detect local aortic vulnerability and
identify novel targets for medical therapeutic intervention.

Public health relevance
NARRATIVE Ascending thoracic aortic aneurysm (ATAA) is a highly lethal event because it renders the aorta vulnerable to dissection, which is the fifteenth leading cause of death in the United States. Due to a lack of understanding of ATAA at the cellular and molecular level, care of patients has been limited to open heart surgery only for advanced-stage aneurysm or for dissection. The two primary objectives of this proposal are to 1) better understand the biology of ATAA to uncover new therapeutic targets aimed at preserving aortic wall integrity and preventing aneurysm progression and 2) develop a multi-parameter, patient-specific (bio)image-based interrogation strategy to develop new diagnostic tools for early detection and better surveillance of ATAA.